Administrative Core

The Administrative Core (AC) provides oversight of all scientific and fiscal aspects of the PPG as well as management of all collaborative activities and coordinating. It will coordinate and organize the meetings of the projects and cores leaders and staff. The core will also organize and facilitate meetings of the Internal and External Advisory Committees. The AC will be responsible for the implementation of decisions, corrective actions, suggestions, and initiatives recommended by the Advisory Committees as well as the project leaders. The AC will provide tools and platforms that will foster the integration, collaboration, and communication within the program. The core will be responsible for all interactions with University of Colorado central resources as well as other institutions involved in this project including the University of Colorado Hospital, National Jewish Hospital, and Stanford University.

Public health relevance
Contact PD/PI: Stenmark, Kurt, R. At the 2013 World Symposium on Pulmonary Hypertension, inflammation was identified as one of the key pathogenic features of pulmonary hypertension (PH). Investigators in this program have played key roles in identifying the potential role of inflammatory cells in the vascular remodeling process that characterizes all chronic forms of PH. This program addresses in three highly integrated and mechanistic projects the role of inflammation, and more specifically the role of macrophages in the vascular remodeling that characterizes the most frequent forms of PH. Through the scope of the projects and the overall infrastructure (three supporting scientific core laboratories), we are poised to provide novel insights into the complex cellular and molecular topophysiology of inflammation in various forms of PH, hopefully leading to identification of translatable new therapeutic approaches for human forms of the disease. Project Narrative Page 190